EFFICACY OF THE XANOMELINE TRANSDERMAL THERAPEUTIC SYSTEM IN ALZHEIMER'S DISEASE

Although neurochemical deficits in Alzheimer's disease (AD) are varied and complex, the earliest, most marked, and consistent neurochemical changes result from the degeneration of the basal forebrain cholinergic neurons which project to the hippocampus and cortex. Degerneration of these ascending pathways result s in deficits in presynaptic cholinergic markers in cortex and hippocampus.